The Collection Methods, Management and Analysis of Data (COMMAND) Core

Project Summary/Abstract
The Collection Methods, Management and Analysis of Data (COMMAND) core will provide support to
COBRE Project Leaders as well as other researchers at Sanford Research and throughout the region
conducting population health research. The core will assist with methodology of research projects including
study design and analysis plans, and provides support for all aspects of data including collection methods,
management, analysis and interpretation. One of the focus areas for the core will be to provide innovative
data collection and management techniques to address the issues unique to rural and American Indian
populations. This is important given the disperse populations and multiple partners that COBRE Project
Leaders will work with. In addition to direct project support, the COMMAND core will also provide training
opportunities in study design, data collection, data management, statistical analysis, and interpretation of
results to improve understanding and further use of more complex and newer methodologies. Overall, the
COMMAND core will enhance current statistical support and integrate data collection and management
strategies appropriate for rural and American Indian populations to help COBRE Project Leaders become
successful, independent investigators.
.

Public health relevance
Project Narrative The Collection Methods, Management and Analysis of Data (COMMAND) core will enhance institutional resources to include support for population health research in rural and American Indian communities. This will entail assistance and training in study design, data collection, data management, statistical analysis, and interpretation of results. The overall goal of the COMMAND core is to promote high quality research in population health with appropriate and innovative methodology